Bone marrow fat and skeletal health in type 2 diabetes

Dr. Kim’s long-term goal is to be a VA physician investigator, elucidating mechanisms of diabetic bone
disease in order to reduce fracture risk in people with diabetes. There is growing recognition that bone disease
is a complication of type 2 diabetes mellitus (T2DM). In T2DM, hip fracture risk is increased by more than a
third, and after fracture, individuals with T2DM have higher rates of postoperative complications and a higher
risk of mortality. Fracture risk is elevated even after controlling for falls, and hip fractures occur despite
preserved or higher bone mineral density (BMD). The fat within the bone marrow is proposed to play a
pathogenic role in diabetic bone disease, as fat and bone are intimately related within the marrow
microenvironment. Adipocytes and osteoblasts share a common mesenchymal stem cell precursor, and
adipogenesis could occur at the expense of osteoblastogenesis. Indeed, greater levels of marrow fat content
are associated with lower BMD and higher fracture risk. However, it is unknown whether marrow fat can be
manipulated to improve diabetic bone disease. Hemoglobin A1c (HbA1c) positively correlates with higher
levels of marrow fat, so enhanced glycemic control might normalize marrow fat and improve bone outcomes.
Given the widespread prevalence of diabetes and the medical and economic costs of fractures, there is an
urgent need to understand diabetic bone disease to identify targeted preventive and therapeutic strategies.
During the Career Development Award-2 (CDA-2) period, Dr. Kim’s goal is to acquire the training and
implement the studies needed to understand the effects of improved glycemic control on marrow fat and bone
health. She will gain expertise in valuable clinical research and translational methods that will position her to
become a leader in the field of diabetic bone disease. Dr. Kim will enroll and follow 75 Veterans with poorly
controlled T2DM (HbA1c 8.5-12.0%) who are working with their clinicians to improve glycemic control. She will
determine the effects of improved glycemic control on bone marrow fat (Aim 1) and the relationship between
changes in marrow fat with bone quality and mass (Aim 2). Pursuit of these aims will involve critical training in
the design and implementation of a prospective cohort study. Dr. Kim will use advanced and sensitive imaging
modalities (including magnetic resonance spectroscopy, high-resolution peripheral quantitative computed
tomography) to assess marrow fat and bone outcomes at baseline and then after 1 year of intensified medical
management. Dr. Kim will also use cutting edge translational methods to explore the role of osteoblast
differentiation as a pathway linking marrow fat and bone outcomes (Aim 3). This will include characterizing
circulating osteoblast progenitor cells by flow cytometry and evaluating expression of osteoblast differentiation
genes. Training in advanced diabetes and lipid metabolism will allow Dr. Kim to interpret these findings and
gain important insights into the pathogenesis of diabetic bone disease. This research is expected to advance
understanding of marrow fat behavior, which may lead to targeted preventive and therapeutic strategies for
diabetic bone disease and osteoporosis. Dr. Kim has assembled a diverse mentorship team comprised of
experts in osteoporosis, metabolism, epidemiology, biostatistics, and radiology. Her training will involve a
combination of individual tutorials with her mentors and scientific advisors, hands-on experience, and formal
coursework. The proposed research will provide Dr. Kim with preliminary data for a larger and longer-term
prospective study of diabetic bone disease, which she will propose in a Merit Review application submitted
before the end of the CDA-2 period. Dr. Kim is committed to improving the health care of Veterans through
clinical research, and with her proposed research and training, she will develop a thriving research program at
the VA.

Public health relevance
Nearly one in four Veterans (1.6 million individuals) receiving care from the Veterans Health Administration has diabetes. The treatment of diabetic complications is integral to Veteran health care. There is growing evidence that the bone is negatively affected by diabetes. People with type 2 diabetes have a higher risk of hip fracture, worse fracture healing, and higher rates of death following fracture. Because of the serious consequences of osteoporosis and fracture, it is critical to understand the mechanisms of diabetic bone disease. Diabetes alters the fat within the bone marrow and may play a role in diabetic bone disease. Understanding how marrow fat affects the bones will provide insight into the mechanisms of diabetic bone disease and could lead to targeted preventive and therapeutic treatments. Further, this research will shape future investigations into diabetic bone disease and osteoporosis.